AI Driven End-to-End 4D flow MRI Pipeline for Hemodynamic Assessment in BAV Disease

SUMMARY / ABSTRACT
Bicuspid aortic valve (BAV) is the most common congenital heart defect (1-2% in the U.S.) which can lead to
severe complications including aortic dilatation or dissection. However, the current risk-stratification paradigm
is based on primitive aortic diameter thresholds and has poor predictive value for outcomes. Studies have
shown that 4D flow MRI can measure in-vivo complex 3D blood flow as risk factors for aortic complications in
BAV. At Northwestern University (NU), 4D flow MRI has been used for hemodynamic assessment of the aorta
since 2011 and we have established a large database with over 4,000 aorta 4D flow MRI scans in >2,000
unique patients and >300 healthy controls. Using this data we have identified promising hemodynamic indices
for risk stratification in BAV. For example, elevated WSS was found to be a novel biomarker for vessel wall
architectural remodeling and identifies patients at risk of progressive aortic dilation.
However, broad clinical adoption of 4D flow MRI is hindered by long scan times (8-15 minutes) and
cumbersome analysis, limiting reproducibility and translation. To overcome these challenges, we developed
deep learning (DL) models to highly accelerate 4D flow MRI acquisition and automate analysis workflows. Our
goal is to build on these findings to establish an end-to-end 4D flow MRI DL pipeline for highly efficient data
acquisition and hemodynamic analysis with full on-scanner deployment. The large NU database of manually
processed 4D flow MRI data (n=4,000+) provides unique ground truth data for training and testing of DL
workflows. To account for variability across sites and MRI systems, DL developments will be augmented by
aorta 4D flow data by our subaward sites, chosen to allow for validation across the main MRI hardware
vendors (NU: Siemens, UW: GE, CU: Phillips). The final DL networks and processing tasks will be embedded
in containerized applications to allow for multi-vendor on-scanner deployment as well as dissemination and
prospective multi-site evaluation.
We aim to 1) rigorously optimize and validate deep learning accelerated 4D flow MRI for the accurate
measurement of aortic hemodynamics; 2) utilize automated hemodynamic analysis to conduct a retrospective
large cohort study with known 10-year BAV outcomes, and 3) conduct a prospective multi-center and multi-
vendor evaluation study of the end-to-end 4D flow MRI deep learning pipeline. This study will introduce
innovative DL methods for 4D flow MRI, assess the role of hemodynamics in BAV 10-year outcomes, and
validate the multi-site feasibility and performance of the end-to-end 4D flow pipeline.

Public health relevance
PROJECT NARRATIVE Bicuspid aortic valve, the most common congenital heart defect, can lead to severe complications, but current risk-stratification methods based on aortic diameter are inadequate. Studies using 4D flow MRI have identified promising hemodynamic biomarkers, such as elevated wall shear stress, that improve risk prediction for BAV patients. To overcome challenges like long scan times and complex analysis, this study proposes a deep learning-based end-to-end pipeline to accelerate 4D flow MRI, automate hemodynamic analysis, and conduct multi-site evaluations for better clinical adoption and outcome prediction.